LARGE AREA DIGITAL IMAGING SYSTEM FOR MAMMOGRAPHY

In mammography, early detection of breast cancer is dependent upon the ability of the imaging system to resolve characteristic distributions and shapes of small microcalcifications in the breast tissue. Approximately 80% of excised breast cancers show areas of calcification on histologic examination. The medical community has not been satisfied with the imaging performance of standard film-screen or current digital imaging technology in its ability to produce the required high quality full field images. The research proposed here would enable the development of a novel imager by combining the high resolution and light output screen with a large-area modified structure a-Si:H detector for mammographic imaging procedures. Specifically we propose to develop large-area high resolution scintillator screens and low-noise a-Si:H detectors needed to carry out this objective. A digital detector system is being investigated that would potentially produce large format mammographic digital images with spatial resolution and detection efficiency superior to current film-screen systems. This system is based on a low-cost modified amorphous silicon (a-Si:H) architecture which takes advantage of the high specific light output of high resolution converter screens specifically designed for this system. In Phase I we successfully demonstrated the feasibility of the concept. In the Phase II project we will continue the research and development which will lead to the fabrication of a large area digital detector technology with a higher sensitivity, resolution, and dynamic range than existing digital systems. PROPOSED COMMERCIAL APPLICATION: Besides the enormous clinical X-ray imaging market, the proposed large area X-ray imaging system would find widespread use in instrumentation wherever high resolution X-ray radiography is used. X-ray radiography instruments currently have a very large commercial market. They may be applied to non-destructive testing systems, diffraction instruments, basic physics research, and other medical imaging systems.